Strategies to Innovate EmeRgENcy Care Clinical trials Network (SIREN) - Pittsburgh

Project Summary and Abstract
This supplement requests support of effort for key individuals that will allow the University of Pittsburgh site for
the Strategies to Innovate Emergency Care Clinical Trials Network (SIREN) to continue operations as a Hub
for recruiting participants into emergency care research. Uninterrupted support of the Hub will ensure
successful enrollment of participants into the following SIREN trials; ICECAP, BOOST-3, and Peds-ICECAP.
We will continue to support the ancillary studies for these trials: PRECICECAP, Bio-BOOST and electro-
BOOST. Our specific Aims remain: 1. Provide administrative structure to rapidly implement and enroll in
clinical trials of emergency treatments. 2. Minimize time, cost and regulatory barriers to multicenter clinical
trials in emergency settings. 3. Explore innovative strategies to increase identification, recruitment, and
consent in emergency treatment trials. 4. Explore innovative strategies to increase quality of emergency care
data and to ensure retention of subjects enrolled in emergency settings.

Public health relevance
Project Narrative Rigorous clinical trials are necessary to improve acute treatment for time-sensitive and life-threatening conditions. The unexpected nature of emergency conditions requires special preparation and skill to recruit and protect participants in clinical trials. Emergency care spans multiple locations including ambulances, emergency departments, intensive care units, and even homes. An experienced research team will implement pragmatic and successful strategies to accomplish enrollment under all these conditions and in all these settings at multiple locations as part of a national emergency care research network.